Cardiac Energy Metabolism and Diastolic Dysfunction in PLWH

People living with HIV infection (PLWH) on ART live longer today but the incidence and prevalence of
chronic diseases is significantly higher that it is in those without HIV. As many as 50% of PLWH today have been
reported to have left ventricular diastolic dysfunction (DD), which is associated with atrial fibrillation, exercise
intolerance, and the progression to heart failure with preserved ejection fraction (HFpEF). The responsible
mechanisms for DD and its progression in contemporary PLWH populations are poorly understood but our
preliminary studies suggest that impaired cardiac energy metabolism may be a central factor linking previously
reported risk factors to DD. ATP is absolutely required for the normal myocellular relaxation and considerable
pre-clinical data and our pilot clinical studies using 31P magnetic resonance spectroscopy (MRS) suggest an
“energetic myopathy” as a basis for the DD in PLWH. In addition, inflammation is increased despite combined
ART and viral suppression in PLWH and is known to impair mitochondrial function. We propose here to examine
cardiac high energy phosphate metabolism, its causes, and its relationship to left ventricular diastolic dysfunction
(DD) and DD progression in PLWH. The central hypothesis is that cardiac mitochondrial energy metabolism is
impaired even in well-treated PLWH, and promotes the development and progression of DD in PLWH as well as
the consequences of DD including cardiac remodeling and HFpEF assessed with echocardiography, increased
circulating heart failure biomarkers, heart failure symptoms and decreased exercise performance. The specific
aims are 1) to define the scope and extent of myocardial energetic abnormalities at rest and exercise using 31P
MRS/MRI in PLWH, 2) to probe the factors underlying cardiac muscle mitochondrial and energetic abnormalities
in PLWH, including those unique to PLWH (ART history and cumulative viral history) and others more common
in PLWH (increased inflammation, immune activation, insulin resistance, cardiac fibrosis, and/or higher cardiac
muscle lipids by MRI), and 3) to determine the functional consequences of observed cardiac muscle energetic
changes in PLWH, particularly the presence and progression of DD. The studies will leverage the expertise,
resources, and established PLWH cohorts at Johns Hopkins and collect novel cardiac energetic, diastolic
function, quantitative exercise tolerance and biomarker data. The results of these studies will deliver novel
understandings of the type and extent of myocardial energetic-mitochondrial abnormalities in PLWH, the factors
prevalent in PLWH that are most closely related to impaired cardiac mitochondrial-energetic metabolism, and
the functional consequences, most importantly diastolic dysfunction. These studies, characterizing the presence
and functional consequences of what appears to be a “mitochondriopathy” of cardiac and skeletal muscle in
PLWH promise new avenues to better understand the pathophysiology of DD in PLWH and suggest the selection
and design of metabolic strategies to reduce the personal and societal impact of HIV disease-related functional
decline in this important and growing population.

Public health relevance
Nearly one-half of people living with HIV (PLWH) today have left ventricular diastolic dysfunction (DD), which is associated with the progression to heart failure with preserved ejection fraction (HFpEF) but the causes of DD and its progression in PLWH are poorly understood. Our preliminary studies suggest that impaired cardiac energy metabolism may be a critical factor for DD in PLWH and thus we propose to examine, in cross -sectional and longitudinal studies, cardiac metabolism in PLWH using sophisticated non-invasive 31P MRI/MRS technologies, reasons for impairment including cardiac lipid accumulation, systemic inflammation, and insulin resistance, and its relationship with echocardiographic and other indices of DD and cardiovascular performance. The results will provide novel insights into the pathophysiology of DD in PLWH and inform the selection of preventive and therapeutic interventions to decrease the burden and consequences of DD in PLWH. `